Targeting Glioblastoma Stem Cells through Epigenetic Reprogramming

Title: Targeting Glioblastoma Stem Cells through Epigenetic Reprogramming
ABSTRACT:
Glioblastoma (GBM) is the most common malignant brain tumor in adult with poor clinical
outcome. There has been a lack of revolutionary improvement in treatment of this deadly
disease over the past 40 years. Any treatment that can significantly prolong patients' overall
survival for more than three months, which is the best achievement so far to treat GBM when
using surgery, radiation therapy and temozolomide, can be considered as a success. Our long-
term goal is to develop novel therapeutic strategies for this lethal disease. GBM cancer stem-
like cells (CSCs) were recently prospectively isolated by several groups and showed resistance
to conventional radiation therapy and chemotherapy. Targeting CSCs therapy brings a hope for
brain tumor patients. The Notch signaling is a developmental signaling pathway that has been
found activated in GBM CSCs. We have demonstrated that Notch inhibition deplete GBM CSCs
and prolong survival in mice bearing intracranial GBM xenografts. A recent Phase I clinical trial
study shows that a quarter of malignant glioma patients have stabilized disease for more than
four month after Notch inhibitor treatment. However, the targets that mediate Notch regulated
GBM CSC self-renewal are largely unknown. As CSCs give rise to non-CSC cells, the major
difference between the two is a different level of gene expression regulated by epigenetics, such
as DNA methylation and histone modification, including acetylation. Our preliminary data from
microarray analysis on Notch inhibitor treated GBM neurosphere showed that an epigenetic
factor Histone deacetylase 4 (DHAC4) is regulated by Notch signaling. Furthermore, our
preliminary studies showed that that HDAC4 is required for GBM neurosphere propagation in
vitro and in vivo. In order to develop new targets to deplete GBM CSCs, the current proposal will
examine the molecular mechanism by which Notch regulates HDAC4 and its impact on GBM
CSCs, and its translational application.
In specific Aim #1, we will define the functional effect of different protein domains of
HDAC4 on GBM CSCs.
In specific Aim #2, we will define the role of Notch and HDAC4 interaction on self-
renewal of GBM CSCs.
In specific Aim #3, we will examine a combination of Notch and HDAC4 inhibition therapy
in GBM patient-derived orthotopic xenografts (PDXs).
Successes in the current proposal will not only discover how an epigenetic factor HDAC4
regulates self-renewal of GBM CSCs and improve GBM treatment, but also will have a clinical
impact on cancer therapy in general.

Public health relevance
Project Narrative: Glioblastoma is the most common malignant brain tumor in adult with very poor prognosis. Developing effective therapy for glioblastoma is in urgent need. We have demonstrated that Notch pathway blockade depletes cancer stem cells in glioblastoma. Recent phase I clinical trials also showed that GSI crosses the blood brain barrier and targets glioblastoma stem cells. In the current proposal, we will investigate how a new Notch target protein regulates self-renewal of glioblastoma stem cells in order to develop other novel therapeutic strategies for this deadly disease.